Towards an Integrated Understanding of Neurotransmitter Dysfunction in Schizophrenia: a Multimodal MRI Study

PROJECT SUMMARY / ABSTRACT
Schizophrenia is among the most severe and burdensome medical conditions worldwide, yet the brain alterations
that lead to the symptoms of schizophrenia remain unknown. This K23 application presents a research and training
program that will support the applicant on a path towards becoming an NIH-­‐funded independent investigator focused
on understanding the neurobiology of schizophrenia and related psychotic disorders. The activities in this application
build on the candidate’s prior training and are set in a resource-­‐rich environment that will foster her development of
expertise in 1) application of MRS and advanced MRI neuroimaging methodologies; 2) physician-­‐scientist approaches to
studying pathophysiology in patients with schizophrenia; 3) neurocircuitry and systems neuroscience perspectives on
hippocampus pathology in psychotic disorders; and 4) responsible conduct of research. The overarching goal of the
research to be carried out in this application is to take findings from animal models of schizophrenia, which were
motivated by original research in patients with the disorder, back to the clinical setting in order to determine whether
the brain circuit alterations observed in the animal models are observable in human patients. Specifically, findings in the
prenatal methylazoxymethanol acetate (MAM) rodent model, which was developed to model the alterations in
dopamine function seen in patients with schizophrenia, suggest hyperactivity of the ventral (anterior) hippocampus may
increase its glutamatergic output to the ventral striatum and lead, via ventral pallidal and other GABAergic projections to
the ventral midbrain, to disinhibited firing of dopamine neurons. In addition, a convergence of several post mortem and
in vivo imaging findings in patients suggests that abnormal GABAergic activity in the hippocampus may further
compound hippocampal glutamatergic overdrive. This project will directly test the relationships among these
neurochemical alterations in individual medication-­‐free patients with schizophrenia using sophisticated magnetic
resonance imaging methods. If this non-­‐invasive, multimodal imaging paradigm provides evidence to relate hippocampal
GABA and glutamate abnormalities to dopamine system dysfunction in patients with schizophrenia, it would have
important implications for our understanding of the brain bases of schizophrenia, and would generate a novel
multimodal imaging paradigm for testing new molecular, anatomical, and circuit-­‐modulating targets for treatment of
this devastating illness.

Public health relevance
PROJECT NARRATIVE In this translational and multimodal imaging study, Dr. Weinstein will use magnetic resonance (MR) acquisitions to obtain measures of GABA and glutamate in the hippocampus, as well as neuromelanin in the midbrain as an index of dopamine. She will examine the inter- ‐relatedness of these transmitter systems in medication- ‐free patients with schizophrenia, compared to controls. This will represent a test in humans of the prominent view in the field derived from clinical and preclinical evidence, proposing that a deficit in GABA function in the hippocampus may lead to hippocampal glutamate excess, which in turn may dysregulate dopamine. If confirmed, this will provide a validated and integrated model of circuit dysfunction that can lead to new therapeutic targets.